Residue-by-residue details of FUS protein phase separation and aggregation

Project Summary
RNA-binding protein aggregates and inclusions are hallmarks of numerous neurodegenerative diseases
including frontotemporal dementia (FTD) and amyotrophic lateral sclerosis (ALS). These nuclear proteins
facilitate fundamental processes including transcription, splicing, and DNA damage repair. While many possess
low-complexity, disordered regions that are critical to their ability to form liquid-like, protein rich condensates that
carry out normal RNA-processing, these same disordered regions enable the proteins to form neural inclusions.
Fused in Sarcoma (FUS) is one of twenty-nine human RNA-binding proteins that contains both a disordered low-
complexity domain (LC) with an unusual composition low in charged residues and high in aromatic residues, as
well as several RGG motif regions. Inclusions comprised of FUS as well as TAF15 and EWS are found in
approximately 10% of FTD cases and dominant mutations in the coding region of FUS cause aggressive forms
of familial ALS. The current hypothesis is that these ALS-associated mutations, many of which are localized in
the disordered domains of FUS, promote contacts that accelerate the liquid to solid transition (LST) of FUS and
ultimately enhance the protein’s aggregation propensity. Several of these aggregated FUS structures, including
aggregated short peptide microcrystals formed in vitro and aggregated full-length protein directly extracted from
patient tissue, are being visualized with techniques such as cryo-electron microscopy (cryo-EM). However, the
self-interactions that drive the formation of FUS assemblies and the mechanism by which physiological FUS
converts to these are currently unknown because the self-interactions of FUS are invisible to traditional structural
biology techniques. To address this gap, we will apply our tools to visualize the dynamic aggregation of FUS with
residue-level resolution. This project will develop advanced nuclear magnetic resonance (NMR) techniques to
identify self-contacts that are critical to the LST pathway. In particular, this project will employ NMR-based
hydrogen-deuterium exchange (HDX), a methodology that has never been applied to the structural details of
FUS, to elucidate FUS residues and regions that are essential to aggregate core formation. Moreover, through
several well-established collaborations, this study will utilize molecular simulations and cellular models involving
FUS aggregates to complement in vitro structural data revealed via NMR-based HDX experiments. These
studies of the FUS aggregation pathway in vitro and in cells will provide essential structure/function information
on future pharmacological targets for inhibiting pathological protein associations in types of ALS. Furthermore,
because FUS is only one of many essential RNA-binding proteins containing aggregation-prone low complexity
domains, the results of the project will serve as a foundation for understanding an entire class of proteins and
for correcting their dysfunctions in disease. These studies in this two-year project will establish new structural
and cellular biology methods applied to disease aggregation and lay the foundation for unraveling how FUS
aggregates form in ALS.

Public health relevance
Project Narrative Here, we investigate several ALS-associated mutations in the disordered N-terminus of FUS, the region of the protein that is essential for liquid-liquid phase separation and the formation of FUS inclusion bodies in ALS pathology. Through NMR-based HDX, molecular simulations, and cell models, we will develop more robust methodology for identifying with residue-by-residue specificity, the self-interactions in FUS that are secondary to ALS-associated mutations and ultimately drive the acceleration of the FUS aggregation. Overall, this project will detail the structural impacts of FUS disease mutations in the context of ALS, provide valuable molecular insights to inform novel ALS therapies, and provide a novel, high resolution methodology for studying the structure and mechanism of protein aggregation.